The function of kidney specific (KS)-WNK1 condensates during potassium stress

PROJECT SUMMARY/ABSTRACT
Potassium [K+]-­deficient diets have contributed to the global epidemic of hypertension and chronic kidney
disease (CKD). Given the low cost and ease of increasing dietary [K+], more research is needed to understand
how [K+] imbalance leads to these diseases. The kidneys handle 90% of [K+], and the distal convoluted tubule
(DCT) acts as a [K+] sensor via the WNK-­SPAK (With-­No-­Lysine/Ste20/SPS-­1-­related proline-­alanine-­rich
protein kinase) pathway. Gain-­of-­function mutations to this pathway lead to severe hypertension and
hyperkalemia by activation of the thiazide-­sensitive sodium/chloride co-­transporter (NCC). Curiously, dietary [K+]
depletion or loading causes the WNK-­SPAK kinases to assemble into large DCT-­specific cytoplasmic puncta,
that are not seen in mice on normokalemic diets. For years, the structure and function of these condensates,
which we call “WNK bodies”, remained a mystery. Dr. Boyd-­Shiwarski’s initial work has identified that these DCT-­
specific puncta are (i) dependent upon the expression of kidney specific (KS)-­WNK1 (ii) potassium-­sensitive;; (iii)
membrane-­less;; (iv) not associated with conventional organelles;; and (v) associated with WNK-­SPAK proteins.
Based on these findings, we hypothesize that WNK bodies are membrane-­less microdomains that sequester the
WNK-­SPAK pathway to modulate WNK signaling during potassium imbalance. This hypothesis will be tested in
two aims that evaluate the physiological significance and biological basis of WNK body formation. This proposal’s
physiology-­based aim will provide Dr. Boyd-­Shiwarski with the opportunity to work with animal models and (i)
implement ex vivo microscopy techniques, (ii) quantify changes in urine, serum, and blood pressure, and (iii)
develop transgenic mouse models. Whereas, the biology-­based portion of this proposal will include
implementation of (i) molecular cloning, (ii) protein biochemistry, and (iii) mass spectrometry and RNA Seq.
These skills will be reinforced by a team of mentors, advisors, collaborators, and core resources available at the
University of Pittsburgh. The primary mentor, Dr. Arohan Subramanya, is an established NIH R01-­funded
physician-­scientist with 13 years of experience in WNK signaling biology and prior experience mentoring over
20 trainees. The co-­mentor, Dr. Tom Kleyman, is an internationally recognized physician scientist who directs
the Pittsburgh Center for Kidney Research, and has mentored nine career development awardees and five R01
recipients within the last 10 years. In addition, an advisory committee of accomplished investigators with
expertise in hypertension, WNK-­SPAK signaling, and renal tubular transport will monitor Dr. Boyd-­Shiwarski’s
progress through biannual meetings. Dr. Boyd-­Shiwarski will use this proposal to accomplish her short-­term goal
of scientific independence and her long-­term goal of becoming a tenure track physician-­scientist with expertise
in potassium homeostasis, hypertension, and CKD. The results from this proposal will form the basis for an R01
studying the translational role of KS-­WNK1-­dependent WNK bodies in human models of nephropathy.

Public health relevance
PROJECT NARRATIVE 98% of the US population does not meet the daily recommendation for dietary potassium intake, and this inadequate potassium intake is directly linked to the development of hypertension and chronic kidney disease. The kidneys handle 90% of the serum potassium, however, the mechanism by which the kidneys sense and respond to potassium imbalance are poorly understood. This proposed study will advance our basic understanding of the signaling pathways in the kidney that respond to potassium imbalance, and thus regulate blood pressure and potassium homeostasis.